DEVELOPMENT OF TANDEM MASS SPECTROMETRY

Development of Techniques VG Autospec 5000 tandem octhogonal acceleration ToF. a) Proteins b) Carbohydrates c) Glycoconjugates (Additional effort and instrument time reported under Collaborative projects and other Technical Research and Development projects.)